Heme Oxygenases: chemically complex enzymes found in diverse biological pathways

Project Summary
This research program will develop accurate, detailed models of enzymatic heme degradation. In
biological systems, heme oxygenases degrade heme to non-heme iron and oxygenated organic products, such
as: biliverdin, staphylobilin, and mycobilin. In eukaryotes, the liberated non-heme iron is ultimately recycled into
iron-dependent proteins. In prokaryotes, heme oxygenases are often part of iron acquisition pathways whereby
pathogenic organisms acquire iron from host-derived heme. Despite a general understanding of the overall
reactions catalyzed by heme oxygenases, the mechanistic details of how these enzymes catalyze the insertion
of two to three oxygen atoms into a heme substrate remain poorly understood. This mechanistic knowledge is
needed to selectively target heme oxygenase without disrupting other heme-dependent proteins. Recently, we
developed new optical assays to accurately measure heme binding constants and elucidate the partitioning of
heme between heme oxygenases and other heme-dependent proteins. We have also discovered an
unprecedented, dynamic out-of-plane distortion of heme within some heme oxygenase active sites, which is
correlated with enzymatic activity. Finally, we have revealed that an active site hydrogen bond promotes heme
degradation in staphylobilin-producing heme oxygenases by stabilizing a resonance structure with a cationic
radical at the carbon site of oxygenation. In the next five years, we will employ a combined spectroscopic and
computational approach to elucidate the mechanism of heme monooxygenation to meso-hydroxyheme by
mycobilin-producing heme oxygenases, and the mechanisms of meso-hydroxyheme oxygenation by biliverdin-
and staphylobilin-producing heme oxygenases. In general, we will employ a variety of spectroscopic
techniques to characterize analogues of key enzymatic intermediates. These experimental data will be used to
develop accurate computational models of the enzymatic reactions. Ultimately, this program will provide
detailed insight into a fascinating chapter of heme biochemistry, namely, self-oxygenation.

Public health relevance
Project Narrative This program will investigate the enzymatic mechanisms of heme oxygenase enzymes using both spectroscopic characterization and computational modelling. Human heme oxygenases are drug targets due to their association with antioxidant and cytoprotective functions, along with neonatal jaundice, and improved fundamental understanding of the enzymatic reaction mechanism will aid these drug design efforts. Heme oxygenases are also part of iron acquisition pathways of pathogenic organisms, and fundamental understanding of these enzymes will aid antibiotic development.